RECOMBINANT VACCINES AGAINST RETROVIRUSES ASSOCIATED WITH LEUKEMIA AND AIDS

Human immunodeficiency virus (HIV) is the etiological agent of acquired immunodeficiency syndrome (AIDS). At present there is no effective vaccine against this disease and therapeutic agents provide only limited help. The objects of this project are to characterize HIV antigens, determine the targets of humoral and cell-mediated immunity, and to use this information to develop candidate vaccines. We have constructed recombinant vaccinia viruses containing HIV genetic information. These viruses have been used as live experimental vaccines to immunize animals, to synthesize HIV proteins in tissue culture, to make targets for cytotoxic T Cells, and study CD4-envelope protein interactions. Our previous studies demonstrated that the HIV envelope protein exists as dimers and tetramers. The question remained, however, whether the envelope protein oligomers could bind multiple CD4 molecules. We have now shown that the dimers, but not the monomers, can bind two CD4 molecules simultaneously. Multimeric CD4 binding may have important implications for env-protein CD4-avidity, CD4-induced release of gp120, subunit-subunit cooperativity during virus membrane fusion, as well as therapeutic strategies. The consequences of altering the ratios of the HIV-1 Gag and Pol proteins were tested by making a single nucleotide insertion that placed the gag and pol genes in the same open reading frame. This alteration led to overproduction of pol gene products including reverse transcriptase and protease and resulted in failure to assemble and bud particles. The block to assembly was partially overcome by inhibition of the protease with a peptidomimetic inhibitor, mutagenesis of the active site of the protease, or shortening of the Gag-Pol polyprotein. These studies provide important insights into the mechanism of HIV particle formation.